Administration

The Administrative Core of the Program Project, Structure and Funcfion of DNA Repair Enzymes, will be responsible for coordinating all of the administrative aspects of the program and for facilitating interactions among the Project and Core Directors, Senior Investigators, and their laboratory members. The overall goal is to insure the successful conduct of the research proposed in this application. The management of the DNA Repair Program will be coordinated by the Principal Investigator/Administrative Core Director, Dr. Susan Wallace, with an Executive Committee comprised of Drs. Bond, Doubli6, Morrical, Pederson and Sweasy. Specifically the aims ofthe Core are: Aim 1. To provide administrative support for the Projects and Cores A and B, Aim 2. To monitor the scientific progress of the Projects by facilitafing monthly meefings of the Program Project participants. Aim 3. To facilitate meefings with the External and Internal Advisory Boards.

Public health relevance
The studies resulfing from this Program will provide insight into how the BER and RAD51 variants in the in the normal population and in tumors may contribute to altereed DNA repair capacity. Hence, this project will both contribute to our understanding of laasic cancer biology and may provide the basis for new approaches to cancer therapy.